Mapping biophysical effects of the cellular environment on p53 and PTEN stability and aggregation

PROJECT SUMMARY/ABSTRACT
Cancers are marked by misregulation of tumor suppressor proteins and changes to the cellular environment
caused by grossly altered metabolic states. It is possible that the altered chemical environment of cancer cells
induces destabilization of a protein’s folded state or protein misfolding and aggregation. Indeed, the crucial tumor
suppressor proteins p53 and PTEN have been observed to form filamentous amyloid inclusions in both wild-type
and cancer mutation-containing backgrounds, perhaps due to conformational landscapes changes caused by
the altered cellular environment. Despite these long-established observations, the causes of p53 and PTEN
amyloid formation remain elusive. Understanding the role that cellular environmental factors and protein
posttranslational modifications (PTMs) play in destabilizing p53 and PTEN and driving amyloid aggregate
formation would provide crucial mechanistic insight into cellular drivers of oncogenesis and uncover new routes
for restoring p53 and PTEN function. Here, we propose to address this gap in knowledge by systematically
testing an endogenous metabolite library and ubiquitination/phosphorylation PTMs for ability to alter p53 and
PTEN thermodynamic stability and induce amyloid formation. Working with recombinantly purified p53 and
PTEN, we will use differential scanning fluorimetry (DSF) to measure metabolite-induced changes in the
apparent melting temperature (Tm), as reported by a fluorogenic dye that detects unfolded protein. Metabolites
that decrease Tm will be considered candidates for destabilizing p53 and PTEN to loss of function, while
metabolites that increase Tm may have a protective effect against sampling conformations that seed amyloid
formation. We will also investigate the ability of metabolites in the library to induce amyloid formation for purified
p53 and PTEN upon isothermal shaking, as measured by the fluorogenic dye Thioflavin T (ThT). Further, we
will perform biophysical and conformational characterization of the resulting aggregates to map conformational
heterogeneity and polymorphism in p53 and PTEN amyloid fibrils. For both soluble and amyloid protein, we will
then screen the Aurora library of conformationally sensitive, fluorogenic dyes to identify potential chemical probes
for molecular recognition of healthy vs. toxic p53 and PTEN proteoforms. In parallel, we will use a biochemical
reconstitution of ubiquitination enzymes and genetically encodable site-specific phosphorylation system to create
p53 and PTEN samples with these crucial regulatory PTMs. In addition to measuring the effects of ubiquitination
and phosphorylation on thermodynamic stability and amyloid formation susceptibility, we will also investigate the
effects of these modifications on protein function, measuring DNA binding ability/affinity for p53 and phosphatase
activity for PTEN. Together, these studies will shed light on the connection between metabolic dysregulation in
oncogenesis and tumor suppressor protein misfolding, dysfunction, and aggregation. This knowledge is
important because a mechanistic understanding of this link will enable new strategies to block cancer
development and create opportunities to tip the scales back towards tumor suppressor folding and function.

Public health relevance
PROJECT NARRATIVE Misfolding and aggregation to amyloid states contributes to loss-of-function phenotypes for the critical tumor suppressor proteins p53 and PTEN in cancer. Changes to cellular environments during oncogenesis may modulate the conformational landscapes of p53 and PTEN, inducing aggregation pathways or stabilizing certain conformational states, but how cellular factors interact with these central signaling proteins has not been systematically investigated. Here, we will use a comprehensive approach to measure the effect of endogenous metabolites and ubiquitination/phosphorylation posttranslational modifications on the stability and amyloid formation propensity of p53 and PTEN, enabling us to develop chemical tools to detect these states and informing new strategies for cancer therapeutics.